Neural representation of perceptual decisions, confidence, and actions in human basal ganglia and thalamus

Project Summary
In planning and carrying our actions we have remarkable flexibility. We can change from
sprinting to carefully stepping when we encounter an icy path, and we can immediately turn
around based on ongoing thoughts, such as remembering that we forgot our keys. This constant
interplay between our thoughts and our actions breaks down in neurologic and psychiatric
disorders. For example, patients with Parkinson’s disease can often quickly walk in a straight
line but are unable to turn around at will. However, the glue that binds cognitive and motor
processes is unknown, and treatments for neuropsychiatric disorders target movement or
cognition separately. In this proposal, we take a different approach – we focus on how brain
structures essential for movement bind our thoughts and actions. This proposal seeks to record
and stimulate the basal ganglia output nodes and motor thalamus, a group of interconnected
deep brain nuclei thought to gate movement initiation. We perform our experiments in awake
human subjects undergoing implantation of deep brain stimulation (DBS) electrodes. Subjects
perform a decision-making task in which they judge the identity or expression of faces, reporting
their choice and confidence about the choice with a reaching movement. In Aim 1, we show that
the neural responses in the output nodes of basal ganglia and motor thalamus are not limited to
encoding movement initiation. We will test the diversity of neural responses, especially co-
encoding of movement kinematics with the confidence, outcome, and reward prediction errors
associated with the movement. In Aim 2, we show that subjects adapt their decision strategy
based on the history of past actions, confidence, and outcomes. We will test whether these
factors are integrated by the neural responses across trials, and whether neural responses in
the output nodes of basal ganglia and motor thalamus mediate adjustments of decisions
strategy. In Aim 3, we will causally test the contribution of the neural responses in these regions
to behavioral adjustments by disrupting the neural activity during precisely-times behavioral
periods in this task. Our experiments will determine how the link between ongoing actions and
thoughts influences future behavior and how this can be modified. The goal is to use the
insights from this research to ultimately develop brain stimulation strategies that treat movement
and cognitive deficits in neuropsychiatric disorders as two sides of the same coin.

Public health relevance
Project Narrative The purpose of this proposal is to understand how the brain plans and executes movements and how it keeps track of and modifies the cognitive strategies that lead to those actions. Understanding this basic brain function will enable development of treatments for neurological and psychiatric diseases that simultaneously affect movement and cognitive function, such as Parkinson’s disease, Tourette’s disorder, and schizophrenia.